Producing Recombinant mRNA in Escherichia coli

PROJECT SUMMARY
The success of mRNA-based vaccines and their modular technology has transformed RNA-
based medicines from a relatively niche area into the mainstream. As research on RNA-based
medicines intensifies, the manufacturing capacity for RNA is increasingly strained. This issue
is further aggravated by the unprecedented advancement of RNA-based therapeutics into
clinical phases. The rising demand for mRNA-based medicines necessitates a scalable, cost-
effective manufacturing process that ensures high yield and consistent quality. Currently,
mRNA manufacturing relies heavily on enzymatic in vitro transcription (IVT). Although the IVT
process has various advantages, its cost and scalability are limited due to the need for multiple
expensive enzymes and chemical reagents.
Moreover, the lack of a standardized process poses another challenge for IVT. A standardized
process for IVT is crucial because variations in the concentrations of ribonucleoside
triphosphate and magnesium ions can dramatically affect RNA polymerase specificity, fidelity,
and productivity. Manufacturing RNA in vivo has proven more cost-effective and scalable than
other methods. However, intracellular RNA production has only been successful for double-
stranded circular RNA or short molecules that can fit into specific stable RNA scaffolds, falling
short for long single-stranded mRNA. Rapid RNA degradation by intracellular RNases and the
heterogeneity of RNA transcripts within host cells hinder mRNA production in vivo and
subsequent purification processes, respectively. Combinatorial approaches, including host cell
engineering, target RNA design, and a compatible downstream purification process, are
proposed to overcome these challenges. This application aims to develop an all-in-one
platform for the intracellular overproduction of long, single-stranded mRNA.

Public health relevance
PROJECT NARRATIVE This application aims to develop a scalable and cost-effective process that can produce high- quality mRNA consistently. To achieve this goal, combinatorial approaches, including host cell engineering, targeted RNA design, and a compatible affinity purification procedure, will be employed to overcome current challenges.